Community Liaison and Recruitment Core

Summary – Community Liaison and Recruitment Core
Although Alzheimer’s disease (AD) and AD-related dementias (ADRD) disproportionally affect older Hispanic
Americans, this population is severely underrepresented in research studies, preventing advances to mitigate
the excess burden and significant societal costs. The Community Liaison and Recruitment Core (CLRC) of the
Alzheimer´s disease AD/ADRD-Resource Center for Minority Aging Research (RCMAR) at the University of
Texas Rio Grande Valley (UTRGV) will build upon the Center's prior success to continue spearheading its
effort to train and support a diverse group of promising scientists in theory-based approaches for the
engagement of older Hispanics, especially Mexican Americans, and their families in social and behavioral
AD/ADRD research. The CLRC will also strengthen existing infrastructure for dissemination and translation of
research advances impacting the engaged communities, and to obtain community feedback and direction
aiming to establish true bi-directional learning, reciprocal expertise transfer, and enhance the Center Scientists’
expertise and commitment. The CLRC's Specific Aims are: (1) Working collaboratively with the Research
Education Core (REC), educate, train, and mentor AD/ADRD-RCMAR scientists in theory and approach to
community engagement for minority health disparities and assist AD/ADRD-RCMAR scientists in recruiting
older Hispanics and their families into their research studies; (2) Expand community-academic partnerships
and capacity to support recruitment and retention of older urban and rural Mexican Americans and their
families in South Texas, especially along the US/Mexico border; and (3) Disseminate research findings to the
scientific community, health care providers, and the South Texas communities served. We will achieve these
aims through strong mentorship of AD/ADRD-RCMAR scientists, linkage of scientists with established
investigators conducting community-based research in rural and urban Hispanic populations, and community
training to facilitate the widespread adoption of best practices for optimizing participation in research studies.
The results will create a state-of-the-art infrastructure for researchers, health care providers, advocates, and
policymakers interested in decreasing health disparities affecting older Hispanics, and in particular those
affected by AD/ADRD. To accomplish these goals, we have built a diverse team of scientists with extensive
experience in community change, community–based research, education, and Mexican American populations.
Scientists involved and collaborating include those at UTRGV, South Texas ADRC, and the World Health
Organization Collaborating Center-Work Group for Community Health and Development at the University of
Kansas; and also health agencies, health care providers, clinicians, and community-based organizations of the
Rio Grande Valley, Texas.